Dynamic and personalized prediction of complex cardiovascular events.

PROJECT SUMMARY
Statistical learning methods such as random forests have proven useful in medical research. With the availability
of massive biomedical and event history data collected during the course of diseases, dynamic and personalized
risk prediction of future clinical events can provide valuable information to identify high-risk individuals and initiate
timely treatments or interventions. Our application is motivated by the NHLBI Pooled Cohorts Study, where risk
factors were measured intermittently at follow-up visits, and multiple cardiovascular disease (CVD) events could
occur during the follow-up period. Existing statistical learning methods usually focus on time to the ﬁrst event with
baseline predictors; methods that can handle the second and subsequent clinical events or repeatedly measured
time-dependent risk factors are lacking. We develop ﬂexible random forest methods for multiple event data, where
the complex event history information is fully utilized without pre-specifying the dependence structure of different
events. The proposed methods can deal with the case where events are of different degrees of clinical importance
and competing risks exist. The methodology will be applied to the pooled cohorts to build accurate risk prediction
tools and to identify important risk factors for both CVD incidence and recurrence. We will conduct validation
analysis to test whether novel statistical learning methods can outperform existing methods such as Cox-type
models; we will also use forest models to provide guidance in building Cox-type models for CVD recurrence. The
proposed research has the potential to advance dynamic and personalized risk prediction and to facilitate more
effective prevention and treatment strategies for CVD recurrence.

Public health relevance
PROJECT NARRATIVE The objective of this project is to develop novel statistical learning methods for predicting complex time-to-event outcomes such as recurrent events. The proposed methodology will have broad applicability; in particular, we aim to address the gap in predicting cardiovascular disease (CVD) recurrence by analyzing the data from the NHLBI Pooled Cohorts Study. The proposed research has the potential to advance dynamic and personalized risk prediction and to facilitate more effective prevention and treatment strategies for CVD recurrence.